USING DEEP MUTATIONAL SCANNING TO CHARACTERIZE TUMOR-IMMUNE INTERACTIONS

Cancer immunotherapy is a new treatment modality that has revolutionized cancer care,
providing benefits to many patients who previously had untreatable disease. However, we still
do not fully understand how this breakthrough treatment works at a molecular level. Deep
mutational scanning (OMS) is a new technique that enables the generation of large-scale
libraries of mutants to understand how changes at the sequence level impact downstream
protein phenotypes. Unlike previous, targeted mutagenesis techniques which were limited in the
number of mutants that could be surveyed, OMS is capable of generating a comprehensive map
of all potential amino acid change in a given protein. I will use OMS to profile how alterations to
PD1, one of the key targets of cancer immunotherapy, impact myeloid cell function. A key
limitation of existing OMS assays is the relatively coarse readouts, such as cell proliferation. In
order to generate a richer characterization of each OMS mutant, I will couple it to single-cell
RNA sequencing to enable fine grained readouts of cell state. I will then use the resulting data to
train a large language model (LLM), a type of mathematical model that is capable of predicting
the impacts of immunotherapy on cell state. This fellowship will give me the tools and
techniques to advance my career, launching me on the path to becoming an independent
investigator at an R 1 institution.

Public health relevance
This project will help to shed light on the key cell types in checkpoint blockade, a cancer immunotherapy that has already shown significant promise in helping patients, and that has the potential to be even more transformative if we could better understand its effects.